Atypical astrocytes in aging and Alzheimer's Disease

SUMMARY.
Astrocytes control neurotransmission, contribute to the blood-brain-barrier (BBB), and shape inflammatory
responses. In healthy aging, many aspects of astrocyte function are altered but what drives aging-related
changes is not well understood. Here, we present exciting preliminary data that during normal aging,
astrocytes take on a novel phenotype in which progressively more astrocytes lose the expression of key
functional proteins. We refer to these as atypical astrocytes (AtAs). AtAs lack expression of excitatory amino
acid transporters (EAATs: GLT-1 and GLAST), that remove glutamate from the extracellular space, Kir4.1, which
mediates extracellular potassium (K+) buffering, and aquaporin-4 (AQP-4), which helps clear A from the brain.
These changes occur on a cell-by-cell basis, with individual astrocytes expressing minimal EAAT, Kir4.1, and
AQP-4, while neighboring astrocytes remain normal. AtAs do not appear to be reactive astrocytes as they lack
elevated GFAP expression and have normal astrocyte morphology. Preliminary iGluSnFR and astrocyte
electrophysiology data suggest that glutamate and K+ homeostasis is compromised in areas where AtAs are
abundant. What causes AtA to form is not known, but published and preliminary studies suggest AtAs are
associated with vascular structures and are found in areas of blood-brain-barrier (BBB) compromise. Our
preliminary data also suggests that AtAs are found in the aging human brain and are more abundant in the
APPNL-G-F model of AD, as compared to WT mice. Therefore, we hypothesize that age-associated vascular
dysfunction drives the formation of AtAs, disrupting astrocyte function and contributing to synaptic and
AD-related pathology. Astrocyte dysfunction occurs late in AD progression, but how astrocytes contribute to
early AD pathology is not well understood. We suspect AtAs occur early in AD progression and contribute
to diverse AD disease mechanisms. Evidence supports that aberrant glutamate signaling contributes to AD
progression. Disrupted AQP-4 expression is a hallmark of AD and associated with reduced A clearance.
Vascular dysfunction is an AD risk factor and astrocytes contribute to BBB integrity. To examine AtAs in a model
of AD, we chose the APPNL-G-F mice due to early onset of elevated soluble A and plaques overlapping with the
normal development of AtAs, without APP overexpression. If our hypothesis is correct, AtAs may be a central
player in aging and AD-related pathologies linking vascular dysfunction to synaptic and A pathology. In this
proposal we will determine 1) What are the molecular and cellular phenotypes of AtAs in the aging and AD
brain?, 2) Do AtAs disrupt synaptic function, ionic homeostasis, and A handling?, and 3) Does BBB
dysfunction contribute to the generation of AtAs? When complete, we will know the molecular and cellular
properties of age-associated AtAs, their effects on astrocyte-mediated homeostasis, and their relationship with
BBB dysfunction. If AtAs mediate astrocyte-neuron dysfunction caused by age-related vascular pathology, it will
represent an entirely new avenue to pursue for treating AD and other age-related neurological disease.

Public health relevance
NARRATIVE. Astrocytes contribute to neuronal activity, blood-brain-barrier function, inflammatory response, and more, but how astrocytes change during aging and in age-related neurological disorders is not well understood. Here we report a novel astrocyte phenotype in normal aging, that is exacerbated in the APPNL-G-F mouse model of Alzheimer’s Disease (AD), known as “atypical astrocytes” (AtAs) in which astrocytes lose multiple functional proteins but do not appear to be reactive. In this proposal we will determine the molecular characteristics of AtA, their functional consequences, and the role of vascular dysfunction in driving AtA formation during healthy aging and in a mouse model of AD.